VALIDATION OF A FREQUENT SAMPLING TECHNIQUE USING DOUBLE-LUMEN CATHETER

This protocol attempts to validate blood sampling technique using a long catheter so that subject could be sampled from outside the room and sleep would not be disturbed.